Mentored Career Development Program

INSTITUTIONAL CAREER DEVELOPMENT CORE (KL2) PROJECT ABSTRACT
The UCSD Clinical and Translational Research Institute (CTRI) CTSA hub is located at the University of
California, San Diego (UCSD). This regional center contains three universities (UCSD, San Diego State
University and UC Riverside), biomedical research institutes (Salk Institute, BIOCOM, Sanford-Burnham
Institute, J. Craig Venter Institute and La Jolla Institute of Immunology), 4 academic hospitals (VA San Diego
Medical Center, Rady Children's Hospital, Eisenhower Medical Center and El Centro Medical Center) and
community partners (San Diego Blood Bank, San Diego County, Community Health Network). The CTSA
program currently encompasses 3 health sciences professional schools (Medicine, Pharmacy and
Engineering) and new collaborations with the School of Public Health, School of Nursing and Jacobs School of
Management. The Education unit has expanded the Master's programs in Clinical Research Enhancement
through Supplemental Training (CREST) Master's in Applied Science to include a Master's in Drug
Development, Translational Science Certificate, and new curricula and innovative modules for the CREST-
MAS program. The overall program goals are to: 1) Develop customized scientific training for a heterogeneous
workforce that creates a pipeline of collaborators and leaders in team science; 2) Improve mentoring and
career development training for KL2 scholars and early-career faculty, focusing on skills relevant to research
career success; and 3) Reduce barriers to team science and heterogeneity in clinical and translational
research careers. The CTRI Mentored Career Development Program (KL2) has supported early-career
investigators seeking careers in clinical and translational research since its inception in 2010. The CTRI KL2
program will provide a mentored research experience for junior faculty that ensures a heterogeneous future
workforce with the requisite skills for outstanding multi-disciplinary research in human health. Mini-sabbaticals,
bootcamps, grant writing workshops and seminar series will offer experiential training to enhance the scholars'
research programs. A Mentoring Core will train mentors in effective methods to engage scholar mentees in
addition to scholar training to become mentors for the next generation of researchers. Outcomes and tracking
will use new informatics tools to determine the impact of the curriculum on long-term research productivity.

Public health relevance
This program enhances clinical and translational research by providing interdisciplinary training and mentorship to early-career investigators. The resulting improvements in research productivity and collaboration will accelerate scientific contributions to human health.